Identification of enzymes inhibited by oncometabolites in Succinate Dehydrogenase mutant tumors

PROJECT SUMMARY
The tricarboxylic acid cycle (TCA cycle, also known as the Krebs cycle) is a fundamental process in eukaryotic
cells, serving as the source for ATP generation and producing reducing equivalents for cell metabolism under
aerobic conditions. In recent years, it has become clear that genes encoding the enzymes in the TCA cycle can
be causative genetic lesions in human cancers, including in inherited tumor syndromes associated with renal
cancer, paragangliomas/pheochromocytomas (PPGL), and Gastrointestinal Stromal Tumors (GISTs) among
others, including epithelial thyroid cancer. They are also well described in sporadic tumors from these same
tissues, as well as in a spectrum of other cancers, including acute myeloid leukemia (AML) and glioblastoma.
Mutations in Krebs cycle enzymes and their related cofactors are thought to cause tumor formation through the
oncogenic effects of excess metabolite accumulation (oncometabolites). These intermediate metabolites act by
interference with the function of enzymes requiring the metabolic cofactor alpha-ketoglutarate (aKG, also known
as 2- oxoglutarate). There are approximately 70 aKG-dependent enzymes in humans, and they perform a variety
of essential cellular functions, including mediating modification of DNA, RNA, and histone proteins. Enzymes of
this class are also responsible for oxidative hydroxylation of proteins, including the structural protein collagen.
We have previously demonstrated using both in vitro and in vivo models for thyroid neoplasia that loss of the
Succinate Dehydrogenase D subunit (SDHD) causes phenotypic changes indicative of early stages of cancer.
Further, this genetic changes causes cells to gain a stem-like phenotype, as evidenced by expression of the
stem cell associated transcription factors Nanog and Oct4 and production of the stem cell marker Aldehyde
Dehydrogenase (ALDH). Despite the fact that interference with aKG-dependent oxygenases has been proposed
as a neoplastic mechanism, no prior efforts have been made to identify family members which are responsible
for the neoplastic change. To fill this knowledge gap, we propose to use a high throughput CRISPR-based
transcriptional repression screen to identify aKG-dependent enzymes whose inhibition leads to a recapitulation
of the stem-like phenotype. Identified hits will be validated using a combination of cellular models and in silico
analysis of tumor-based omics data. The Aims for this R03 pilot proposal are as follows:
1) To use a CRISPRi screen to identify alpha-ketoglutarate (aKG) dependent enzyme(s) whose inhibition
leads to the acquisition of a stem-like phenotype
2) To validate identified enzymes in cell line models and in human tumor datasets
Identification of the enzymes whose functions are affected by accumulation of the oncometabolite succinate will
shed important new light on the molecular mechanism of disease associated with Sdhx and other TCA cycle
mutations, and will provide a stepping stone for future research grants that will allow detailed delineation of
genetic and/or protein targets that drive tumor formation in the thyroid and other tissues (e.g. glioma, leukemia).

Public health relevance
PROJECT NARRATIVE Genes encoding enzymes in the tricarboxylic acid cycle (TCA cycle, also known as the Krebs cycle) are causative genetic lesions in human cancers, including both inherited tissue-specific tumor syndromes and a variety of sporadic cancers. These tumors are associated with the accumulation of oncometabolites which interfere with an enzyme family of ~70 members that use alpha-keto-glutarate (aKG, also known as 2-oxo-glutarate) as a cofactor. In this application, we will use a CRISPRi-based screen to identify and perform pilot validation of the aKG-dependent enzyme(s) whose inhibition by oncometabolites leads to the acquisition of the neoplastic phenotype.